Center for Coordination of Analysis, Science, Enhancement, and Logistics (CASEL) in Tobacco Regulatory Science - Leadership and Logistics Core

PROJECT ABSTRACT – LEADERSHIP AND LOGISTICS
The Leadership and Logistics Core (LLC) will serve as the nexus of the Center for Coordination of Analytics,
Science, Enhancement and Logistics (CASEL), coordinating and integrating the work of the other Cores as
part of a larger whole and serving as the connection between CASEL, Federal partners, and the tobacco
regulatory science (TRS) research community. Scientific leadership activities of this Core will capitalize on our
unique central position in the TRS community to identify research priorities for the purpose of advancing the
science in meaningful ways and leverage the expertise within the community to provide timely data and
findings to support regulatory action. Logistical activities of the Core will be focused on communication and
providing the resources, tools, and structure to support committees, Special Interest Groups (SIGs), scientific
meetings, and processes for collaboration and product development. Oversight and management of CASEL
activities in all Cores will emanate from the LLC, under the leadership of CASEL MPIs Ms. Jeanne Rosenthal
and Dr. Robin Mermelstein. Ms. Rosenthal will have primary responsibility for managing logistical and
administrative functions of the Center. Dr. Mermelstein will provide scientific guidance and direction. Ms.
Miriam Galbraith will serve as Program Manager, leading CASEL's logistics team, coordinating the day-to-day
activities of the Center, and serving as primary liaison to the Federal partners. Our experienced team will build
on the robust infrastructure, community networks, and relationships and a record of substantial scientific and
logistical accomplishments of the Center for Evaluation and Coordination of Training and Research (CECTR)
and CASEL 1.0 to carry out the work of this Core for CASEL 2.0.